5th Annual International Symposium: Improving Breast Cancer Management and Outcomes

Project Summary/Abstract: The overall objective of this scientific meeting is to strengthen capacity for breast cancer management to ameliorate breast cancer management disparities in the low ? and middle-income countries (LMIC) and developed world. This objective reflects the growing burden of breast cancer in LMCI, with a comparable paucity of infrastructure and little investment in the field of research. The symposium will serve to improve awareness of multidisciplinary breast cancer management and outcomes in LMIC and United States. The conference content seeks to shift clinical paradigms by engaging breast cancer care providers and researchers to develop recommendations for early detection and management of breast cancer that improves the evidence-base for breast cancer intervention in LMIC. Due to limitations of resources, both technical and of workforce, as well as social determinants of breast cancer incidence, the breast cancer research and treatment paradigms from high- income nations cannot merely be extrapolated with minor adaptations to low-resource settings. This meeting will leverage the expertise and experience of participants to foster novel concepts, approaches, methodologies, and interventions specific to low-resource settings, where breast cancer is often an under-developed field. The research plans and demonstration projects will encourage the application of these new concepts, approaches, methodologies, and interventions, along with rigorous evaluation to improve the evidence- base. While the experts engaged in this field are enthusiastic, the financial limitations of international travel often restrict their ability to meet. Furthermore, this conference has a schema that will render itself to ample discussion, dissent, and integration of viewpoints from the different disciplines. The format and agenda of the symposium are designed specifically to address its specific themes. The meeting is structured to allow for brief presentations on each focus area by experts to improve knowledge sharing, followed by in-depth facilitated discussion to encourage the generation of novel approaches and stimulate collaboration. The four-day meeting is structured to achieve the themes with brief presentations on each focus area. Day-one and two which are full day of workshops and hands-on and training, covers Surgery, Pathology, Radiology and other topics. The second half (day-three and four) will be an in-depth presentations starting with individual country breast cancer public health epidemiology. Day-four is a compilation of translational research and practical application of evidence-based procedures that includes topics of surgery, pathology, radiology, oncology, palliative care and precision medicine with discussions chaired by field experts.

Public health relevance
Project Narrative: This conference addresses the great need for scientific discourse on cancer in LMIC and the United States, and the formation of goal and action-oriented multidisciplinary teams. Breast Cancer is a growing cause of morbidity and mortality in low- and middle-income countries (LAMICs); current health systems and research initiatives in these countries must improve engagement with breast cancer to stem the increasing burden of this dreadful disease. Successful completion of the conference will change the concepts, methods, and technologies used to study breast cancer in LMIC by driving innovative scientific discovery through collaborative translational research.